Mechanisms of EDC Effects via Small-RNA Cargo in Sperm Epididymosomes

ABSTRACT
Exposures to environmental endocrine-disrupting chemicals (EDCs), especially during early life, are strongly
linked to adverse health outcomes. Furthermore, EDC exposures to the fetus, which also expose the germ cells
(precursors to sperm and egg) within the fetus, can cause heritable epigenetic changes that are passed to future
generations. Previous work has implicated epimutations of DNA CpG methylation as one molecular mechanism
by which EDCs program the germline. Proposed work will explore this mechanism, which is under-studied, and
in addition, seek to understand how external factors from the male reproductive tract involved in sperm
maturation may themselves contribute to epimutations. More specifically, the proximal portion (caput) of the
epididymis has a substantial influence on sperm during their final steps of maturation. Extracellular vesicles
(EVs) from the epididymis – epididymosomes - released from the epithelium fuse and transfer their diverse
molecular contents to sperm, including small noncoding RNAs (sncRNA), thereby contributing to the functional
competency of sperm and to the developmental trajectory of a fertilized embryo. These sncRNAs have the
capacity to regulate gene expression and direct DNA methylation in sperm. In the current proposal, we will
establish whether and how two different EDC classes that signal via differing hormonal mechanisms cause direct
CpG methylation changes to DNA, and/or change the transfer of sncRNA content of epididymosomes to sperm
to indirectly cause epimutations. The two EDC classes studied here are the polychlorinated biphenyl mix Aroclor
1221 (A1221), an industrial mixture that has weakly estrogenic properties; and vinclozolin (VIN), an anti-
androgenic fungicide. Both EDCs are still environmentally relevant. Rats are exposed to human relevant dosages
of A1221 or VIN, or vehicle, through feeding the dams during gestation and lactation. In adult male rats, sncRNA
cargo of EVs from caput epididymis and mature sperm from the cauda epididymis will be extracted and used for
deep sequencing and bioinformatics. DNA from sperm in the same samples will be subjected to reduced
representation bisulfite sequencing to identify epimutations in CpG islands. These data will establish a definitive
epigenetic profile that will allow us to pinpoint the origin of EDC induced epimutations. This proposal is
biomedically relevant, as all humans are exposed to EDCs, with mechanisms of sperm maturation highly
conserved across mammals.

Public health relevance
PROJECT NARRATIVE All humans are exposed to environmental endocrine-disrupting chemicals (EDCs) from industry, agriculture, and plastics. Exposures of the germ cells – precursors to sperm and eggs – are of particular concern because molecular changes instigated in germ cells may be inherited and lead to disease in future generations. Proposed work seeks to identify the molecular mechanisms by which developmental EDC exposures cause epigenetic changes in sperm through deep sequencing and bioinformatics related to small noncoding RNAs in extracellular vesicles and DNA methylation, in order to develop potential interventions for exposed humans and their offspring.